Clinical Support Services for the NIAMS Intramural Research Program

This project has provided research infrastructure support for FY22 for the clinical protocols listed below. These protocols serve a variety of research needs for investigators in the NIAMS.

03-AR-0173: Studies of the Natural History, Pathogenesis and Outcome in Autoimmune and Inflammatory Diseases Including Juvenile Dermatomyositis

11-AR-0223: Studies on the Natural History and Pathogenesis of Spondyloarthritis

12-AR-8001: Compassionate Use Treatment Protocol 14V-MC-JAGA Treatment of Autoinflammatory Syndromes Expected to Benefit from JAK 1/2 Inhibition

18-AR-0081: Investigation of the Natural History, Genetics and Pathophysiology of Systemic Juvenile Idiopathic Arthritis and Adult-onset Still's Disease and Related Inflammatory Conditions

91-AR-0196: Studies on the Natural History and Pathogenesis of Polymyositis, Dermatomyositis, and Related Diseases

01-AR-0227: Natural History of Rheumatic Disease in Minority Communities OK Check

14-AR-0200: Studies of the Natural History, Pathogenesis and Outcome of Idiopathic Systemic Vasculitis

15-AR-0165: Study of the Natural History, Pathogenesis and Outcome of Melorheostosis-a Rare Osteosclerotic Disease

03-AR-0131: Genetic Determinants of Ankylosing Spondylitis Severity - Longitudinal Study

04-AR-0205: Progression of Spinal Fusion in Ankylosing Spondylitis

15-AR-0185: Safety of Tofacitinib, an Oral Janus Kinase Inhibitor, in Systemic Lupus Erythematosus; a Phase Ib Clinical Trial and Associated Mechanistic Studies

15-AR-0060: The Role of PPAR-gamma Agonists in Immunomodulation and Vascular Prevention in SLE (PPAR-SLE)

94-AR-0066: Studies of the Pathogenesis and Natural History of Systemic Lupus Erythematosus (SLE)

13-AR-0056: Stopping Anti-TNF Agents in Rheumatoid Arthritis (STARA) Trial

15-AR-N010: Frequency and Complications of Major Orthopedic Procedures in Medicare Beneficiaries

96-AR-0102: Standard Care Dermatology; Evaluation and treatment of subjects with dermatologic diseases Check

18-AR-0035: Topical ruxolitinib in cGVHD; Phase II study of topical ruxolitinib for cutaneous chronic graft versus host disease (cGVHD)

13-AR-0071: Anakinra in Pustular Dermatoses; A phase 2 study of anakinra in inflammatory pustular dermatoses: evaluation of therapeutic efficacy and validation of pathogenic mechanisms

000207: SAD-COVID: The natural history of coronavirus disease (COVID-19) in systemic autoimmune diseases; an observational prospective study OK

20-AR-0032: Glucocorticoid Genomics in SLE; Genomic effects of glucocorticoids in patients with systemic lupus erythematosus OK

13-AR-0005: STOP LUPUS: A phase 1b, randomized, double-blind, placebo controlled study with an open label extension to evaluate the safety and tolerability of Omalizumab, a humanized IgG1 monoclonal antibody in patients with lupus (STOP LUPUS)